Modeling the influence of translation-elongation kinetics on protein structure and function

Project Summary An emerging paradigm in molecular biology is that translation kinetics can influence nascent protein behavior. Introducing synonymous codon mutations into an mRNA molecule, which changes the rate at which codon positions are translated by the ribosome but not the amino acids they encode, has been shown to influence whether a nascent protein will fold and function, misfold and malfunction, aggregate, or efficiently translocate to a different cellular compartment. The genomes of different species use synonymous codons with different frequencies, suggesting that mRNA molecules may encode an additional layer of information to guide the variation in translation speed across a coding sequence and thereby influence the fate of a protein. Indeed, synonymous mutations that can change translation rates have now been linked to a variety of diseases, including subtypes of hemophilia and cancer. These findings are a shift away from the prevailing view that a protein's amino acid sequence alone encodes its structure and function to one in which the kinetics of protein synthesis are relevant to in vivo protein behavior. As the coupling been translation kinetics and nascent protein behavior has been relatively understudied, many fundamental biological questions about this phenomenon remain unanswered. These questions include: what are the molecular origins of codon translation rates? How can we model the influence of translation elongation kinetics on protein structure and function? How do changes in translation speed lead to the experimentally observed changes in the folding and function of the Cystic Fibrosis Transmembrane Conductance Regulator protein and the clock protein KaiB? In this research program, a range of computational tools will be developed and applied to address these questions. These tools include coarse-grained molecular dynamics simulations, chemical kinetic modeling, and bioinformatics techniques. Such computational tools are well-suited to address these questions as they provide a means to simulate protein synthesis at the molecular level, explore the impact of changing codon translation rates on nascent protein folding and function, and extract molecular information relevant to translation kinetics from Next-Generation Sequencing data sets. Additionally, a number of anticipated findings from this research will be tested by our experimental collaborator. This proposal will advance the nascent proteome field by examining details of these biomolecular systems that are difficult to measure experimentally, by providing molecular explanations for experimental observations, and by challenging the field's current paradigms to motivate entirely new research directions.

Public health relevance
Narrative statement Until recently, synonymous codon mutations, which change the rate at which a codon position is translated by the ribosome but not the amino acid it encodes, have been ignored as potential causes of disease. This perspective is changing as more diseases, including some forms of cancer, are being linked to this class of RNA mutations. This research proposal seeks a basic molecular understanding of how synonymous codon mutations alter codon translation rates and influence nascent proteins to misfold and malfunction in potentially disease- inducing ways.